Empathy for Everyone: Generative AI that Improves Patient-Provider Cultural Attunement in Real Time

Abstract
It is estimated that more than one in five U.S. adults live with a mental illness (57.8 million), with many racial
and ethnic minorities (REM) groups reporting higher risk of persistence and disability from mental illness than
their White counterparts. Despite widespread demand, more than half of U.S. adults (roughly 28 million)
needing mental health treatment do not receive care. Treatment-seeking is particularly low among REM. Even
among REM treatment-utilizers, 30-57% terminate prematurely, yielding poor treatment outcomes. Primary
drivers of drop-out for REM include diminished client involvement and weak patient-provider alliance. This
poses a particular challenge for retention as REM frequently fear that providers will be ill-equipped to respond
to their mental health needs in an empathic, affirming manner. Equipping providers with innovative technology
that facilitates cultural attunement in real-time, particularly for REM patients, is essential for addressing mental
health disparities in the U.S. and globally at scale. Attunement in mental health care involves the provider
accurately understanding and responding to the client’s lived experience. Cultural attunement goes a step
further to describe the providers’ awareness and responsiveness to the intersections of societal context,
culture, and power in client experience. Cultural attunement has been shown to be a key element that retains
REM in mental health services.
DMH applications, including telehealth and chat-based treatments, have unprecedented access to the content
of treatment and quality of conversations and may therefore allow researchers to understand the key
conversational moments, predictors of success, and mechanisms of change in culturally-attuned treatment. To
our knowledge, we–mpathic.ai–are the first company to build capacities to detect and correct for cultural
attunement in real-time with natural language processing (NLP) and generative artificial intelligence (AI)
technologies. The current SBIR Phase I proposal is from a highly skilled and interdisciplinary team with
expertise in automated evaluation of health services. In this SBIR Phase I project we will employ AI and NLP
processing on conversational data from 300 hundred, 30-minute health coaching sessions (60% REM) to
improve cultural attunement in provider-patient interactions in real-time. The
product to be developed for this
SBIR will specifically: (1) detect behaviors vital to patient-provider alliance and cultural attunement, and (2)
offer real-time correction to improve clinical outcomes . We will compare our AI model outputs to human
labelers and patient-ratings of therapeutic alliance and cultural attunement. We will also pilot dissemination of
our technology with 50% of providers from our collaborators at Wave Life Inc., a mental health platform, to
gather key acceptability and feasibility data prior to launching a randomized control trial of our technology as
part of a Phase II SBIR.

Public health relevance
Narrative The COVID-19 pandemic demonstrated the potential for Digital Mental Health (DMH) to meet the growing mental health crisis in the U.S., including the ability to reach historically underserved groups such as racial/ethnic minorities (REM). DMH use increased 7x between 2015 to 2021, however, much of this growth has been fast paced with little to no attention to cultural factors that are key to improved health outcomes. The goal of this SBIR Phase I project is to develop applications of artificial intelligence (AI) and natural language processing (NLP) for mental health equity by providing AI augmented real-time feedback, analysis and coaching on cultural attunement during mental health treatment—defined most commonly as provider behaviors that demonstrate awareness and responsiveness to the intersections of societal context, culture, and power, and that have been found to be a key ingredient in retaining REM in treatment. Copyright © BBC Entrepreneurial Training & Consulting Facilities_Other_Resources_Example_NIH_v00.doc